Technology Core

Point of Care Technologies for Nutrition, Infection and Cancer for Global Health (PORTENT)
3.0 Technical Core
Abstract
The PORTENT Technical core describes our process for advancing promising global health relevant
point-of-care technologies for infection, cancer and nutrition towards clinical viability. We describe herein
(1) our process for soliciting and selecting new projects from the US, our clinical partners, and from around the
world, (2) how that process will be fundamentally guided by our annual needs assessment consensus, (3) how
we will support team building through our partnership network, (4) how the clinical core will enable deployment
and validation of the selected technologies, and (5) how the dissemination core will support: commercialization
through the global health lab-to-market accelerator, training of project participants, and dissemination of results.
To take maximum advantage of the resources we can deploy, at full capacity will focus on supporting 6-7 parallel
projects that either are beyond the proof-of-concept stage and would benefit from clinical validation, have been
validated or even commercialized domestically but are looking to expand to international settings, or have been
developed/incubated by our international partners and show promise at addressing a market need in the US.
Illustrative of what we will fund throughout the effort we provide four PoC project proposals originating from
Cornell, Columbia, Massachusetts General Hospital, and the St. Johns Research Institute (India) that we
intend to fund in year 1. These projects address specific needs which are defined in our initial needs
assessment consensus and include early screening of cervical cancer, comprehensive determination of
iron status enabling anemia screening, combined HIV and multiplexed detection of sexually transmitted
diseases, and broader, cheaper, and more accurate malaria testing. Each of these teams will partner with
at least one of our clinical sites to validate of their technologies and our dissemination core to train users workers
and engage developers in clinical rotations. Beyond year 1, new and continuing will be solicited from around the
world with our broadly disseminated RFP and selected based on a series pre-defined criteria which include: fit
with needs assessment consensus, technological readiness, milestones, contribution to capacity building, and
project team. By the end of year 5 we anticipate that we will initiate 20 independent point of care
technology projects, of which 30% will originate from outside the US and 80% will transition to a larger
funding opportunity, licensing arrangement or start-up company.